Community-based, client-centered prevention homes to address the rural opioid epidemic

Contact PD/PI: WESTERGAARD, RYAN
PROJECT SUMMARY
The scope of our supplemental application is consistent with our original submission. The below summary is
from our original submission.
In response to RFA-DA-17-014, HIV, HCV and Related Comorbidities in Rural Communities Affected by Opioid
Injection Drug Epidemics in the United States: Building Systems for Prevention, Treatment and Control
(UG3/UH3), we propose a multi-phase, mixed-methods study that aims to implement and evaluate a novel
community response model, which we have named the Community-Based, Client-Centered Prevention Home.
Using the organizational infrastructure of a large, multi-site syringe service program serving a geographically
disperse population of people who inject drugs in rural communities across Northern Wisconsin, we will build
locally responsive systems to facilitate uptake of evidence-based prevention services for high-risk clients. The
Client-Centered Prevention Home model incorporates prevention case management and mobile health
information technology into traditional harm-reduction services delivered at syringe service programs, which
we hypothesize will increase use prevention services. During the UG3 phase, we will perform needs
assessments in 6 rural Wisconsin counties in partnership with local stakeholders, and use respondent driven
sampling to conduct a cross-sectional epidemiologic evaluation to estimate the prevalence of HIV, viral
hepatitis and sexually transmitted infections. Contingent upon meeting recruitment and data collection goals, in
the UH3 phase of the project we will deploy and evaluate the Client-Centered Prevention Home model in the 3
counties demonstrating highest vulnerability to worsening epidemics of opioid injection. The 3 remaining
counties not selected for implementation will serve as comparison sites in a quantitative evaluation of program
effectiveness during year 5. The growing problem of opioid injection in rural Wisconsin is highly significant
because it exemplifies trends observed nationally indicating severe vulnerability to worsening epidemics of
HIV, HCV, and opioid overdose deaths in rural communities that are substantially underserved by evidence-
based prevention interventions. This proposal is highly innovative because it will be the first study to use an
evidence-based mHealth strategy and a formal implementation science approach to enhance coordination of
prevention services in syringe service programs. It has potential for high impact because of our team's state-
wide reach, broad access to at-risk individuals, and robust infrastructure for conducting a rigorous, multi-site
evaluation of our proposed model.
Project Summary/Abstract

Public health relevance
Contact PD/PI: WESTERGAARD, RYAN PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE The scope of our supplemental application is consistent with our original submission. The below summary is from our original submission. Rural-dwelling people who inject heroin and other opioids are a highly marginalized population. Poor access to medical and prevention services leaves residents of many rural U.S. communities vulnerable to preventable harms of injection opioid abuse. The overall objective of this project is to implement an innovative yet widely replicable service delivery model which we have named the Community-Based, Client-Centered Prevention Home. The project will use mixed-methods to conduct a comprehensive needs assessment in 6 rural counties across Northern Wisconsin. Using an implementation science framework, we will develop and evaluate a service coordination model within an existing network of rural syringe service programs. Innovative features of this approach include use of a mobile health application to enhance the reach of prevention case managers, who will facilitate clients' access to a comprehensive package of 9 evidence-based prevention services.